Laminar Circuit Motifs for Working Memory and Language Combinatorics: From Cells to Systems

PROJECT SUMMARY / ABSTRACT
Language gives meaning to our inner thoughts, interacting with cognitive functions that flexibly manipulate
sensory content in mind. Language combinatorial capacities create meaning by combining symbols (words) and
rely on an extensive neural system, which when affected by neurological impact leads to disorders of language,
memory and thought. Although animal models have deeply informed understanding of neural systems for which
there are correspondences to human cognition, such as those for working memory, the neuronal mechanisms
of language and its entanglement with cognitive function remain poorly understood. The proposed
interdisciplinary team will seek to break through the status quo by leveraging a comprehensive research program
that can provide a well-powered study of human language and working memory interactions with unique scalable
data capable of resolving neural function across neocortical layers from single cells to systems. Aim 1a: Our
language Combinatoric Transformations via Working Memory (CTWM) task will be conducted with up to 100
patients across our neurosurgical partnering sites during high-density laminar array recordings in the operating
room from two key brain areas involved in language combinatorics and working memory. Aim 1b: Insights on
neuronal function across the cortical layers will be deeply informed by unprecedented information from single-
cell genomic and spatial transcriptomic analyses applied to tissue samples after task performance and the
laminar array recordings. Aim 2a is to investigate laminar information flow across the cortical array in local field
potentials, and Aim 2b in interaction with available (non-laminar) subdural intracranial EEG recordings from
other brain areas. Aim 3a is to pre-operatively scale insights to system-wide levels using laminar fMRI in the
same patients with the same task, and Aim 3b will integrate the combined neurophysiological and neuroimaging
data via a next-generation generative biophysical model. The anticipated outcomes are first-in-human insights
on the interplay between language and cognition, unique openly shared multi-modal data and a model that could
be applied world-wide to accelerate the understanding of human laminar circuit motifs in health and disease.

Public health relevance
PROJECT NARRATIVE A hallmark of human intellect is our ability to flexibly manipulate information in working memory and for language to apply meaning to it, however the neuronal mechanisms supporting this uniquely human neural entanglement remain poorly understood from cellular to systems levels. The proposed interdisciplinary team will pursue a transformative understanding of working memory and language interactions by leveraging high-density laminar array recordings in neurosurgery patients during their operating room treatment procedures—allowing access to single units and local-field potentials distributed across cortical layers—complemented by unprecedented single-cell genomic and spatial transcriptomic insights from tissue samples after task performance and the array recordings. High-resolution laminar fMRI will be pre-operatively obtained in the same patients and with the same task to allow investigating system-wide interactions, and the combined datasets will be integrated across scales with a next-generation biophysical model to advance mechanistic understanding of human laminar circuit motifs and how working memory and language interact to organize and give meaning to our inner thoughts.